Targeting the CD73-adenosinergic pathway in head and neck cancer

Head and neck squamous cell carcinoma (HNSC) related to tobacco and alcohol consumption is aggressive and
responds poorly to available therapy. Even the new PD-1/PD-L1 immune checkpoint blockade is insufficient to
control progression due to other highly immunosuppressive conditions in the tumor microenvironment (TME).
Compelling evidence implicates the ecto-5'-nucleotidase (NT5E) CD73 as another important immune checkpoint,
as high CD73 expression in the TME of many tumors, including HNSC, is linked to poor patient survival.
Several consistent TME conditions, such as hypoxia and treatment, cause an increase in extracellular (e)ATP,
and CD73 serves at the last, rate-limiting step in concert with CD39 and other ectoenzymes, to convert eATP to
adenosine (eADO). eADO activates adenosine receptor (AR) A2AR to suppress T cell activation, while A2BR
promotes immunosuppression via cancer-associated fibroblasts (CAF) and myeloid cells present in the TME.
Studies, including our own, show that CD73 and A2BR, and to a lesser extent A2AR, are expressed in the highly
immunosuppressive TME of progressive HNSC of both clinical and preclinical samples, suggesting their role in
the immunosuppression. However, the contributions of molecules downstream of CD73 are poorly understood.
Recent rapid advances in spatial analysis of the TME have revealed a critical role of immune effector to target
cell distance in generating productive antitumor immunity with impact on clinical outcomes. Because eADO is
short-lived, the spatial relationship between CD73 on one hand and A2AR or A2BR on the other hand, is likely to
affect the specific AR activated by eADO. We discovered in HNSC clinical specimens that A2AR is rather limited
and located remotely from CD73, which supports the hypothesis that the major immunosuppressive impact of
CD73-AR immune checkpoint is mediated primarily through the CD73-A2BR axis.
Our plan is to: (1) dissect how the CD73-A2BR pathway regulates the immune landscape in the TME of ectopic
preclinical HNSC models during progression and treatment; (2) develop effective CD73-ADO-A2BR ICB regimens
in preclinical models of orthotopic and in primary carcinogen-induced tongue HNSC; (3) assess the relationships
between HNSC patient peripheral blood myeloid precursors, levels and distribution of CD73 and A2BR on myeloid
and CAF subsets in the TME, patients’ three-year post-operative outcomes.
Impact: The proposed study will identify CD73-A2BR-dependent mechanisms of immunosuppression in HNSC
preclinical models and develop translatable therapeutic intervention. The results will provide highly valuable
insights into the effects of CD73-A2BR axis on disease progression and the therapeutic potential of blocking it.

Public health relevance
Public health narrative This study will focus on understanding the biological mechanisms and clinical implications of the CD73- adenosinergic checkpoint in head and neck cancer on tumor progression and following radiotherapy, which greatly impacts patient survival. This study is highly relevant to human health and the results obtained in this study will lead to the rapid development of translational strategies to improve cancer treatment and maximize therapeutic gains.